METABOLIC RATE AND PROTEIN, CARBOHYDRATE AND LIPID METABOLISM IN OBESITY

This study continues to examine the underlying mechanisms for the high incidence of weight gain in reduced weight obese subjects, caucasian vs african americans.